Core A: Administrative Core

PROJECT SUMMARY/ABSTRACT: Administrative Core
The overall goal of our leukemia focused ARTNet Research Center is to understand how the architecture of
resistance is governed by temporal extrinsic and intrinsic factors in order to identify novel therapeutic strategies
to stay ahead of tumor evolution and adaptation in patients with Acute Myeloid Leukemia (AML). To achieve this
goal, we have assembled an exceptional team of leukemia researchers that bridge basic/mechanistic and
preclinical/translational research who have worked extensively together for 15+ years studying AML biology. The
Administrative Core will provide leadership, scientific oversight, governance, integration, and administrative
support to the ARTNet Research Center to ensure effective operations, communication, internal and external
collaborations, compliance, and rigorous scientific evaluation of ARTNet Consortium funded projects. The
Administrative Core co-Leads, Dr. Jeffrey Tyner (Contact M-PD/PI) and Dr. Cristina Tognon, have been working
together for close to a decade, and they have also both worked closely for this entire time with Administrative
Core Biostatistics and Bioinformatics Lead and Overall M-PD/PI, Dr. Shannon McWeeney. They will be
supported by a highly experienced Research and Finance Administrator, Sarah Bowden. The specific aims of
the Administrative Core are to: 1) Provide overall administrative management by providing governance and
scientific integration of the Center and developing and implementing a staffing plan; 2) Create an environment
that fosters a focused and synergistic relationship between the Projects and the Cores; 3) Provide ARTNet
Research Center compliance oversight and evaluate scientific progress; and 4) Enable rapid dissemination of
data and resources. To achieve these aims, the Administrative Core will establish and implement ARTNet
Research Center governance, including establishing a Scientific Advisory Board (SAB) to help evaluate the
Center’s progress toward its aims and milestones; plan regular strategic interactions and meetings; develop
communication plans; ensure budget oversight and compliance; manage intellectual property issues; complete
annual progress reports; facilitate regular and timely communication; facilitate collaboration within the Center
and with external collaborations; and perform all other administrative duties required to support the ARTNet
Research Center and its successful participation in the Acquired Resistance to Therapy Network.